How do stem cells decode proto-oncogenic Ras signaling to eliminate hyper-proliferative cells in vivo?

PROJECT SUMMARY
Most adult organs are composed of differentiated and stem cells and are maintained at a constant size through
a process of dynamic turnover: organs lose differentiated cells as they age and eventually die, but are replen-
ished by stem cell divisions. However, while stem cell divisions are crucial for normal homeostatic turnover,
excessive divisions can result in hyperplasia and ultimately cancer. Therefore, a key problem faced by adult
organs is how to promote enough stem cell divisions to replace aging cells without generating so many cells
that the organ becomes hyperplastic. Studying how this balance is robustly maintained in healthy organs is
crucial for understanding how it breaks down in the early stages of tumor development. Throughout metazoan
tissues, stem cells are triggered to divide through activation the Ras-Raf-MEK-ERK signaling cascade. Unsur-
prisingly, activating mutations in this pathway are found in ~30% of human tumors. In particular, over half of
colorectal cancers are characterized by mutations in the RAS gene. However, expression of these mutants in
the intestinal cells of mice and flies is insufficient to generate colorectal tumors. What explains this apparent
contradiction? Evidence from multiple in vivo systems suggests that when Ras-Raf-MEK-ERK signaling ex-
ceeds physiological levels, safeguard mechanisms are evoked to counteract nascent hyperplasia and preserve
tissue homeostasis. Yet, how stem cells distinguish overactive signaling from physiological signaling and how
tissues suppress hyperplasia remains poorly understood. Here, I will study these questions using the Drosoph-
ila adult midgut, a stem cell-based organ that is functionally equivalent to the vertebrate intestine. While Ras
signaling underlies homeostatic stem cell proliferation in this organ, my preliminary data shows that sustained
expression of constitutively active Ras mutants in progenitor cells generates a biphasic response where stem
cell proliferation on short time scales (12-24 hours) is paradoxically followed by a striking decrease in the num-
ber of progenitors over longer timescales (24-72 hours). I hypothesize that this depletion of progenitors is trig-
gered by a “persistence detector” mechanism that distinguishes between physiological and proto-oncogenic
Ras signaling based on the duration of activity. Using a combination of advanced genetic tools, high-resolution
confocal microscopy, single-cell RNA-sequencing, and pharmacological manipulation I aim to understand 1)
How differential activation dynamics for different genes modules downstream of Ras generate a biphasic re-
sponse to RasV12 expression, 2) What dynamic feature of RasV12 signaling distinguishes it from physiologi-
cal Ras signaling, and 3) How interactions between different cell trigger the later phase decrease in progenitor
cells in response to RasV12 expression. Overall, my findings will shed light on the fundamental mechanisms
for decoding signaling pathway activity and may ultimately inform approaches for treating cancer.

Public health relevance
PROJECT NARRATIVE Ras activation induces stem cell divisions that are required for normal organ homeostasis and regeneration, but excessive activity can cause uncontrolled organ growth and cancer. In this proposal, I will study how organs detect and respond to excessive Ras activity to maintain organ homeostasis and inhibit tumor formation.